Dietary lipids as drivers and therapeutic targets in obesity-accelerated breast cancer

Summary
Diet-induced obesity affects about 40 percent of US women and increases the incidence, morbidity, and
mortality of postmenopausal breast cancer (BC). Obesity also increases the risk of large, high-grade tumors,
metastasis, and recurrence regardless of menopausal status. Our long-term goal is to contribute to the
development of new therapeutic approaches for the treatment of obesity-associated human BC. Our research
proposal addresses this by interrogating the mechanisms by which dietary lipids accelerate BC tumor growth,
and whether BC in patients with obesity have unique metabolic vulnerabilities that can be leveraged
therapeutically. Supported by published evidence and our own preliminary data, our central hypothesis is that,
in settings of chronic dietary lipid overabundance such as obesity, BC cells are wired to utilize free fatty acids
(FFA) over glucose to support cancer lipid anabolism, resulting in accelerated tumor growth. The insulin
sensitivity and health of the adipose microenvironment dictate whether tumors source these lipids locally or
from systemic metabolism. We will test our central hypothesis by pursuing three specific aims: 1) Test if dietary
lipids, rather than glucose, are preferentially utilized by BC cells in lipid-rich environments, 2) Determine the
metabolic fate of absorbed fatty acids in breast tumors and 3) Assess the translational implications of an
altered metabolic program to the treatment of BC in patients with obesity. In aim 1, we will use different dietary
and genetic mouse models that can accelerate BC growth to quantify the relative uptake of dietary fuels and
their source in lean versus obese BC. In aim 2, we will use stable isotope infusions to trace the fates of dietary-
derived FFAs and establish their biochemical contributions to tumor growth. In aim 3, we will use
pharmacological inhibitors of lipolysis and circulating FFA-lowering agents to test the therapeutic potential of
restricting FFA supply for inhibiting tumor growth. We will also analyze the expression of lipid metabolism
genes in human BC stratified by body mass index as a measure of obesity status. Our approach, which
collectively addresses physiology, adipose biology, and tumor metabolism, is enabled by our combined
expertise in nutrition and metabolic status (Dr. Chaix), adipose tissue biology (Dr. Hilgendorf), and in vivo
stable isotope tracing to study tumor metabolism (Dr. Ducker). Together, we have established a system in
which BC tumor growth can be accelerated solely by the manipulation of circulating levels of lipids,
independent of adiposity and associated metabolic syndrome. This lipid-centric view of tumor metabolism
generates strong testable hypotheses for future therapeutic interventions. Specifically, we propose that
pharmacological and dietary interventions targeting cancer metabolism need to be optimized for the lipid
metabolic program of the tumors which is determined by the metabolic health of the patient.

Public health relevance
Narrative Persons with obesity have an increased risk of developing breast cancer. Our proposed research will address how obesity increases breast cancer growth and suggest new drugs to treat these patients. Thus, the proposed research is of high relevance to public health and perfectly aligns with NCI mission to support cancer research to advance scientific knowledge and help all people live longer, healthier lives.